Toll-like Receptor 4 and Transforming Growth Factor Beta Receptor Stimulation in Macrophages Regulate Prostaglandin-mediated Inflammation and Direct Wound Healing

PROJECT SUMMARY/ABSTRACT Non-healing wounds in patients with Type 2 Diabetes (T2D) are a major cause of morbidity and mortality and are increasing at an alarming rate. Equally concerning, our current “standard of care” leaves 70% of diabetic wounds unhealed. Given this substantial impact on patient outcomes and healthcare expenditure, a critical unmet need exists for improved understanding of the pathophysiology of diabetic wounds and to develop effective treatments. Under normal wound healing conditions, the macrophage (Mφ) transitions from an inflammatory phenotype, which is prone to tissue destruction, to a reparative cell. In T2D, inflammatory Mφs fail to transition to the reparative phenotype and the molecular mechanisms behind this are not elucidated; leaving a large deficit in our ability to prevent and treat these wounds. Using human cells and our experimental murine models of wound healing, our lab has shown the prostaglandin E2 (PGE2) pathway is persistently elevated in diabetic wound Mφs and that this leads to impaired wound healing. Prior research by others and our lab has identified that both toll-like receptor 4 (TLR4) stimulation and increased levels of transforming growth factor (TGF)β1 are present in diabetic wounds and lead to upregulation of cyclooxygenase-2 (COX-2), the enzyme necessary for PGE2 production. We hypothesize that upregulation of TLR4 and TGFβ1 in T2D Mφs leads to increased COX-2 expression and PGE2 production, and that targeted therapy will reverse these processes leading to decreased pro-inflammatory Mφs and improved wound healing. This hypothesis will be investigated through the following specific aims: 1) Elucidate the TLR4-mediated regulation of Mφ-specific COX-2 expression in normal and diabetic wounds. We will also test the therapeutic efficacy of TLR4 antagonists in vivo. 2) Investigate the TGFβ1-induced miR-29b/DNA methyltransferase regulation of COX-2 expression in normal and diabetic wound Mφs and evaluate the therapeutic efficacy of local TGFβ receptor antagonists and COX-2 inhibitors targeted to wound Mφs.

Public health relevance
PROJECT NARRATIVE Non-healing diabetic wounds are the most common cause of amputation in the United States with a 5- year mortality rate of nearly 50% and annual cost to the healthcare system of $19 billion. This study will examine how increased signaling of the toll-like receptor 4 (TLR4) and transforming growth factor (TGF)β1 pathways in diabetic wound macrophages lead to a persistent pro-inflammatory state that is detrimental to wound healing and will test macrophage-targeted therapy to modulate these pathways and reverse pathologic inflammation. The success of human and animal studies outlined in this proposal will lead to improved understanding of the pathophysiology of non-healing diabetic wounds and test novel therapeutic targets.